AORTIC DISSECTION WITH THE ENTRANCE TEAR IN TRANSVERSE AORTA

Clinical and necropsy findings are described in 12 patients who had fatal aortic dissection with the entrance tear in the transverse aorta. The 12 patients represent 7% of the 181 cases of spontaneous aortic dissection seen at necropsy in the Pathology Branch, National Heart, Lung, and Blood Institute, during a 30-year period. The ages of the 12 patients at death ranged from 37 to 87 years (mean 67); 8 were men; 8 had a history of systemic hypertension, and 10 had hearts of increased weight. Diagnosis of aortic dissection was made during life in only 4 of the 12 patients. All 12 patients died of rupture of the false channel within 2 weeks of onset of signs or symptoms compatible with aortic dissection. The direction of aortic dissection from the entrance tear was entirely retrograde in 4 patients, entirely antegrade in 4 patients, and in both directions in 4 patients. Hemopericardium occurred in the first group, left hemothorax in the second group, and either in the last group. Of the 8 patients in whom the ascending aorta was involved, the retrograde dissection in each extended into the wall of aorta behind the sinuses of Valsalva, 6 had pulmonary adventitial hemorrhage, and 4 had involvement of the arch arteries by dissection. In the 4 patients who had strictly antegrade dissection, none had dissection involving the arch arteries. Thus, tear in the transverse aorta causes a dissection which is usually fatal, which often dissects retrogradely and which may mimic dissection from a tear in ascending aorta. Aortic dissection from a tear in transverse aorta requires immediate operative intervention.